Validation of a LAMP assay for rapid and cost-effective detection and management of CRE colonized veterinary patients

Abstract
Carbapenems are among our most precious broad-spectrum antimicrobial drugs because they are the
therapy of choice for life-threatening invasive bacterial infections. Unfortunately, the increasing
frequency of use of carbapenems has led to the emergence and dissemination of carbapenem-resistant
Enterobacterales (CRE) in human healthcare where heavy selection pressure and population-dense
environments favor the emergence and spread of highly resistant strains. CRE are now also emerging as
an important antimicrobial resistance threat in veterinary medicine. Healthy companion animals in the
community can become asymptomatically colonized with CRE in their enteric microbiota through normal
contact with food, other animals, humans, or the natural environment including surface waters. If these
animals later require veterinary care for unrelated health conditions, there is risk that their CRE
colonization will be unrecognized and that the CRE will subsequently contaminate the hospital
environment where other patients and staﬀ may then be exposed. The emerging threat of CRE to
hospitalized veterinary patients has been described for multiple outbreaks. Unfortunately, accurate and
cost-eﬀective rapid screening tests that can provide a result in time for colonized patients to be
identiﬁed and appropriately managed during hospitalization to prevent transmission are not available.
These tests will be needed in order to implement eﬀective surveillance and CRE infection control
programs in veterinary settings. We are proposing to validate a rapid screening test for CRE colonization,
implement for surveillance in our hospital patient population, and share the results with the veterinary
community regarding the identiﬁcation and management of CRE colonized veterinary patients. To
accomplish this, we propose to validate a LAMP assay as a screening test for patient CRE colonization
using both experimental and observational methods. Our experimental method will utilize canine feces
spiked with CRE at multiple dilutions to establish the ability and sensitivity of the LAMP assay to detect
CRE in fecal samples. Observational data will be generated to validate the LAMP assay by testing OSU
VMC patient fecal swabs in parallel with selective culture, and by testing blinded samples of known
status provided by a collaborator. Once validated, we will then implement the LAMP assay for ongoing
surveillance of CRE colonization in our patient population. That data on patient CRE colonization will
allow us to make patient management and intervention decisions within 24 hours of patient admission.
We will then disseminate information regarding LAMP assay performance and our implementation to
other Vet-LIRN laboratories and to the veterinary community through scientiﬁc meetings and continuing
education.

Public health relevance
Narrative Carbapenem Resistant Enterobacterales (CRE) are emerging as an important antimicrobial resistance threat in veterinary medicine, threatening not only animal health but also the public health. Unfortunately, accurate and cost-effective rapid screening tests for CRE colonization that can provide a result in time for colonized patients to be identified and appropriately managed during hospitalization to prevent transmission are not available. We are proposing to validate a LAMP assay for CRE colonization, implement the assay for surveillance in our hospital patient population, and share our results with Vet-LIRN laboratories and the veterinary community regarding the performance and implementation to support management of CRE colonized veterinary patients.